Understanding dynamic correlates of children's telomere length: The interplay between cumulative risk exposure and relational processes

Project Summary/Abstract
Reductions in telomere length (TL), a biomarker of cellular stress, are linked with later atypical human
development, including elevated risk for psychopathology, chronic disease, and mortality. Understanding
factors that either positively or negatively impact children’s TL is needed to enhance children’s long-term
health and well-being. Currently, stress-inducing adverse experiences (risk exposures), such as household
economic strain, exposure to violence, and neighborhood disadvantage, have both an independent and a dose-
dependent effect on TL, with the occurrence of each additional adverse experience accelerating TL shortening.
Prior work in this area is limited, however, in that it has conceptualized risk exposures as static rather than
dynamic and has failed to investigate protective factors that mitigate the effect of cumulative risk exposures on
children’s outcomes. The proposed project aims to (1) examine how fluctuations in cumulative risk exposure
are prospectively associated with children’s telomere length and (2) examine how parents’ supportiveness
towards each other serves as a moderator between cumulative risk exposure and children’s telomere length. To
achieve these aims, the research team will conduct a dyadic, longitudinal analysis of data from the Fragile
Families and Child Wellbeing Study (FFCWB). Findings from this project will contribute to a broader
understanding of factors that positively or negatively impact children’s TL and elucidate sensitive periods in
which cumulative exposure to adverse experiences may be most harmful for children.

Public health relevance
Project Narrative The proposed research is relevant to the public health because reductions in telomere length are associated with later atypical human development, including elevated risk for psychopathology, chronic disease, and mortality. Upon completion of the project, we will have a broader understanding of factors that positively or negatively impact children’s telomere length and elucidate sensitive periods in which exposure to adverse experiences may be most harmful for children. Such findings would inform applied work by highlighting where specific resources would be useful to enhance children’s health and well-being.